Adipose tissue as a novel facilitator of tumor growth and cachexia

PROJECT SUMMARY
A majority of patients with lung cancer experience cancer cachexia (CC), a complex syndrome where the
tumor dysregulates host tissue metabolism, leading to adipose tissue (AT) and skeletal muscle wasting.
Despite known associations of CC with increased fatigue, treatment toxicity, and poor prognosis, little is known
about the early mechanisms leading to tissue wasting. Reflecting this lack of understanding, no effective
therapies are currently available to treat CC, which is in part due to the rapid development of currently
available preclinical models of CC. These current models hinder our ability to understand how early
pathological changes initiate CC, and how substrates released from wasting tissues impact tumor development
and growth, knowledge that is essential for developing effective treatments for CC. To address this, we
established a Kras-driven model of lung CC that progresses more slowly. Unlike other preclinical models of
lung CC, this model develops tumors in the lungs, shares genetic characteristics with tumors in patients that
predispose to lung CC, and better represents the metabolic properties of human lung tumors. Our preliminary
data implicates adipose tissue wasting as an effector of tumor growth and tissue wasting in this model, as AT
loss predates muscle wasting and is inversely associated with tumor growth. Furthermore, pharmacological
inhibition of lipolysis reduces tumor growth in vivo but does not directly prevent tumor cell growth in vitro,
suggesting substrates released from AT support tumor growth. Dietary fats are known to increase cancer
incidence and are stored in AT for use as energy substrates. Based on our preliminary data we hypothesize
that endogenous fat substrates from wasting AT and exogenous fat substrates from the diet have a dual
pathological importance in supporting rapidly growing, treatment-resistant tumors and CC. To test our
hypotheses, we will employ pharmacological inhibition of lipolysis, our novel, genetically engineered mouse
model, and a combination of ex vivo and in vitro modeling of tumor, adipose, and muscle to dissect the
contributions of substrates released from AT in supporting tumor growth and promoting muscle loss during CC
progression. Results from these studies will address critical knowledge gaps about how tumor characteristics
relate to CC, providing a foundation for clinical translation. This proposal upends the perspective that AT
wasting during CC is a unidirectional product of tumor-derived factors to affect the host, and instead shifts the
role of AT from a passive partner of muscle wasting to an effector of pathological consequence for not only CC,
but also for tumor growth. Knowledge from these studies could broaden the range of potential therapeutic
targets to treat CC and the inciting cancer.

Public health relevance
PROJECT NARRATIVE The majority of patients with lung cancer experience cancer cachexia, a debilitating syndrome characterized by loss of skeletal muscle and adipose tissue. This proposal utilizes a novel mouse model of lung cancer cachexia to study the role of adipose tissue wasting in the development of aggressive tumor characteristics and muscle wasting. Successful completion of these studies could redefine adipose tissue loss during CC from a passive partner to a consequential facilitator of tumor growth and skeletal muscle wasting in Kras-driven lung cancer, distinguish novel therapeutic targets for CC and the inciting cancer, and identify diet modifications as a potential adjunctive therapy in lung cancer.